Prefrontal mechanisms underlying polydrug heroin and alcohol use

PROJECT SUMMARY
Opioid use disorder (OUD) is often comorbid with other drug use, and alcohol is one of the most commonly co-
used drugs. Yet most of the basic research on OUD has been conducted in single-drug use models. Current
FDA-approved treatments for OUD target the endogenous opioid system directly, either as substitution therapies
(e.g. buprenorphine, methadone) or antagonists that oppose opioid effects (e.g. naltrexone, naloxone). These
treatments establish the mu opioid receptor (MOR) as a major therapeutic target for OUD. Similarly, opioids have
been implicated in the pathophysiology of alcohol use disorder (AUD), and naltrexone is used to treat both OUD
and AUD, further underscoring the overlapping mechanisms between these disorders. As the seat of executive
function, the prefrontal cortex plays an integral role in the inhibitory control over drug craving and relapse.
Humans with substance use disorders (SUDs) exhibit structural and functional changes in the prefrontal cortex,
accompanied by deficits in cognitive function. Thus, the prefrontal cortex may be a key locus for opioid-induced
adaptations that impact SUD severity. My lab has identified the rodent infralimbic (IL) prefrontal cortex projection
to the nucleus accumbens shell (ILNAshell) as an important limiter of heroin seeking. Within the IL cortex,
interneurons express MORs, and layer 5 pyramidal neurons (which give rise to the NAshell projection) express
5-HT2A receptors. Furthermore, we have recently demonstrated the ability of a 5-HT2A agonist to reduce opioid
and alcohol seeking (in single-drug use models), and these effects were long-lasting after a single treatment.
Thus, 5-HT2A agonists are an emerging class of therapeutics for OUD and AUD, and they may act upon
prefrontal cortex microcircuits to elicit these effects. This proposal aims to examine these two receptor systems,
with a focus on the prefrontal cortex, in a preclinical model of polydrug heroin and alcohol use. This model
incorporates chronic comorbid alcohol exposure, initiated prior to heroin self-administration and continuing
throughout the period of opioid exposure. The overarching objectives of this project are to identify the role of 5-
HT2A receptors in drug seeking after comorbid heroin and alcohol self-administration, to define the role of the
ILNAshell circuit in drug seeking after polydrug use, and to determine how polydrug exposure alters intrinsic
excitability of different neuronal populations in the infralimbic cortex and the regulation of neuronal excitability by
5-HT2A and MOR. These receptors are positioned to regulate excitability of cortical sub-circuits, with each
predicted to culminate in increased ILNAshell output, and therefore increased inhibitory control over drug
seeking. Information gained from this project will provide insight into whether heroin and alcohol polydrug use
elicits neuroadaptations in cortical sub-circuits that are oppositional, additive, or otherwise distinct. It will also
shed light onto how these circuits are regulated by 5-HT2A and MOR, both of which are druggable targets with
known or emerging therapeutic applications for SUDs. Collectively, this will provide the groundwork for
understanding how treatments can best be tailored to individuals with comorbid opioid and alcohol use.

Public health relevance
PROJECT NARRATIVE Opioid use disorder is frequently accompanied by chronic alcohol use, yet preclinical models of polydrug opioid and alcohol use are lacking. This project will determine the basic mechanisms underlying heroin seeking after comorbid alcohol use, with a focus on the prefrontal cortex, a key brain site whereby drugs highjack decision- making. These studies will lay the groundwork for understanding how prefrontal receptors and circuits are differentially impacted by opioid use versus opioid use with chronic comorbid alcohol use, thus guiding treatment strategies in individuals with a polydrug use history.